Reproductive and Child Health StaRR Program

SUMMARY
The objective of this R38 is to increase the number of next generation physician-scientists that can apply
knowledge of microbiology, immunology, and research techniques for the improvement of reproductive, maternal
and child health. We request support for 4 physician-scientists in pediatrics or obstetrics/gynecology residency
to complete one year of laboratory-based immunology or infectious disease training. The major strength of our
program is the world-class faculty mentors that span expertise across bacterial and viral infectious diseases,
immune system development, infectious disease immunology, autoimmunity, allergy, cancer immunology and
vaccines, immunodeficiencies, innate and adaptive immunity, vaccinology, antibody response, functional
genomics of the immune system and response, and immunotherapeutics. Our program features a training
program that combines research with an R38 seminar series to strengthen and build our students’ critical
thinking, scientific communication, responsible conduct of research, and skills in navigating academic medicine
unique to physician-scientists. Our trainees will benefit from the rich, diverse, and interactive infectious disease
and immunology community at University of Washington and our Seattle partner institutions: Benaroya Research
Institute, Fred Hutchinson Cancer Center, and Seattle Children's Research Institute. During and after their R38
year, we will provide trainees with opportunities to interact with one another to build a community of early-stage
physician-scientists in reproductive, maternal and child health. Our R38 Seminar Series features training not
only in scientific communication, but also in leadership strategies, professionalism, negotiation, and work-life
balance that are critical for navigating hurdles in academic medicine. A unique highlight of the program is an
ongoing commitment to scholars after completion of their award by providing mentoring in grant writing for their
first K38 or other career development proposals by a team of dedicated faculty members. Our program features
five Specific Aims: 1) to provide innovative scientific training in immunology and infectious diseases focused on
reproductive and child health, 2) to create and support effective mentor-mentee relationships, 3) to enhance
success in transitioning to career development awards through grant writing mentorship during and after the R38
award, 4) to recruit and support resident physician-scientists from diverse backgrounds, and 5) to evaluate
scholars, mentors and the overall program. In summary, we will leverage the rich scientific environment that
supports infectious disease and immunology research in Seattle to enhance the career development of
physician-scientists in reproductive, maternal and child health.

Public health relevance
NARRATIVE The objective of our R38 training program is to support medical residents in pediatrics and obstetrics/gynecology who intend to pursue infectious disease and immunology research. Our goal is to increase the number of next generation physician-scientists that can apply knowledge of microbiology, immunology and research techniques for the improvement of reproductive, maternal and child health.